TESTOSTERONE REPLACEMENT ON INSULIN SENSITIVITY/SECRETION IN HYPOGONADAL MEN

This objective of this study is to determine the efficacy and safety of treating hypogondal elderly men with replacement doses of intramuscular testosterone on insulin sensitivity and secretions dynamics.